The role of immunosuppression and environmental exposures on incident and subsequent keratinocyte carcinoma risk after solid organ transplant

PROJECT SUMMARY
Keratinocyte carcinomas (KCs), which include squamous cell and basal cell carcinomas of the skin, are the most
common type of cancer in the U.S. with over 5 million new cases annually. The immune system plays a pivotal
role in KC development and progression via immunological surveillance. Immunocompromised solid organ
transplant recipients face an exponentially increased risk of KC, with significantly higher risks of KC-related
morbidity and, in some cases, mortality. The more aggressive tumor biology in the setting of immunosuppression
of solid organ transplant recipients also serves as a model for other diseases where immunosuppression is the
mainstay of therapy (e.g., rheumatologic diseases, immune-mediated gastrointestinal disease). Yet, due to
limited data on the factors influencing this relationship, there remains no risk-individualized approach to KC
screening, surveillance and management in transplant recipients. This critical unmet need represents a missed
opportunity to reduce incident and recurrent KC and achieve superior skin cancer-related outcomes in this high-
risk population. Although exposure to ultraviolet (UV) rays from sunlight and skin type have been extensively
studied as the major cause of KC in the non-transplant setting, they are not included in existing skin cancer risk
scores for solid organ transplant recipients. Key limitations of existing skin cancer risk prediction models for solid
organ transplant recipients also include a lack of immunosuppression treatment variables. Together, these have
led to a lack of evidence-based guidelines for KC surveillance and management, contributing to suboptimal KC-
related outcomes in organ transplant recipients with preventable morbidity and possibly even mortality.
Addressing these knowledge gaps would lead to more accurate KC risk stratification in the immunosuppressed
population and for an individualized approach to treatment decision-making that considers the necessary
balance of immunosuppression to prevent rejection with skin cancer treatment options. We will leverage a pre-
existing data source of linked national transplant registry data and data from the Veterans Health Administration
(VA), along with a prospective multi-center cohort study of a diverse population of kidney and liver transplant
recipients to develop two clinically-useful sets of deliverables with the potential to change practice: (i) validated
prediction models to standardize KC screening and surveillance in a high-risk population and (ii) a Markov
simulation model to enhance immunosuppression-related decision-making for patients who experience post-
transplant KC. To achieve these objectives, we will: a) derive and internally validate a model that includes
immunosuppression treatment variables to predict incident and subsequent KC in a retrospective cohort of
kidney and liver transplant recipients in the VA; b) externally validate and refine these models in a prospective
diverse multi-center cohort of kidney and liver transplant recipients, capturing detailed data on UV exposure, skin
type, and photosensitivity; and c) construct a Markov simulation model to guide immunosuppression-related
management strategies for incident and subsequent KC.

Public health relevance
PROJECT NARRATIVE Immunosuppression increases the incidence, morbidity, and mortality of basal cell (BCC) and squamous cell carcinomas (SCC), especially in solid organ transplant recipients who have a 10- to 65-fold increased risk of these cancers. However, a lack of clinically applicable risk models with high discrimination and calibration has led to a paucity of evidence-based guidelines to manage BCC and SCC in immunocompromised patients. This grant seeks to: 1) derive and internally validate a prediction model for BCC and SCC in a retrospective cohort of kidney and liver transplant recipients with available immunosuppression treatment data; 2) externally validate and refine this risk model in a multi-center prospective cohort of kidney and liver transplant recipients that includes detailed data on sun exposure and skin type; and 3) develop a simulation model to better weigh the risks and benefits of changing immunosuppression to reduce subsequent BCC and SCC risk and guide immunosuppression-related management of kidney and liver transplant recipients who develop a BCC or SCC.